Ultra-Long-Acting Polymeric Injectable Multi-Purpose Prevention Technology for Contraception and HIV Prevention

PROJECT SUMMARY
Globally, over 50% of those infected with HIV are women, and annually, ~50% of all pregnancies are unplanned.
Therefore, there is a critical need to promote female-controlled methods of multipurpose prevention technologies
(MPTs) and delivery strategies that can be disassociated from the sex act. Injectable formulations are well
tolerated by men and women, are efficacious for contraception, and have high patient acceptability and
compliance1-4. Innovations recently introduced into the field of systemic PrEP are long-acting (LA) formulations
of antiretrovirals (ARVs) that stably release drugs over many weeks as nano-formulations and have activity in
animal models of prevention5-7 and in humans8-10. Currently, there are two different LA formulations being
considered for HIV prevention: a LA form of rilpivirine (RPV/TMC278) and a LA form of cabotegavir
(CAB/GSK744)9, 11-12. Injections of these LA ARVs requires a 4-week ‘lead-in’ regimen using oral cabotegravir or
rilpivirine to fulfil current safety considerations as once injected these agents have detectable levels for months
and the drug cannot be removed or have its clearance accelerated. Despite these advances in HIV PrEP,
currently there are no LA injectable MPT formulations in development mainly because of limitations of current
LA injectable formulations utilizing nanoparticle suspensions whereby two drugs cannot be combined into a
single injection. In this R01 grant and building on our existing data, we propose a comprehensive evaluation of
a first-in-line injectable MPT that offers durable and sustained protection from HIV transmission, high efficacy of
contraception, increased user compliance, and the ability to be removed in case of unanticipated adverse events
or when considering discontinuation from the LA HIV PrEP and/or contraception. We will achieve this goal by
developing a liquid MPT formulation utilizing excipients that form a biodegradable depot after subcutaneous
injection (in-situ forming implant (ISFI)). We propose a comprehensive evaluation of this novel drug delivery
approach using a highly relevant macaque model of mucosal simian/human immunodeficiency virus (SHIV) as
an invaluable preclinical tool to assess the efficacy of the ISFI against SHIV acquisition. This cutting-edge
combined approach will be utilized to evaluate the scientific premise of our proposal to investigate whether
sustained protection against HIV acquisition and pregnancy can be achieved using a unique and highly
innovative ultra-long-acting coitally-independent MPT ISFI formulation.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The benefit of multipurpose prophylaxis to women with high risk of HIV/STIs infection is significant. Ultra-long- acting injectable formulations providing steady release over several months of antiretroviral drugs in combination with a contraceptive drug can potentially increase compliance to STIs and unplanned pregnancy prophylactic regimen and transform the HIV prevention landscape. The overarching goal of this proposal is to develop and evaluate a first-in-line injectable multipurpose formulation that can contribute to curb the HIV epidemic.